ASPIRE, Advancing Scientific Potential through Inclusive Research Experiences

The aim of the current proposal is to build and expand upon the pilot Summer Research Program
(SRP) that has been successfully established at the VA Boston Healthcare System (VABHS) over the
past three years. This program will perpetuate the mission of enhancing the diversity of the basic and
translational research workforce at VABHS and beyond, by providing hands-on research opportunities to
undergraduate and medical students from underrepresented groups coupled with an outstanding
mentoring experience. The anticipated outreach early in the students’ academic development is intended
to enrich the diversity of the pipeline for the scientific workforce of the future, which will ultimately enhance
the quality, innovation, competitiveness and creativity of VA supported research.
Our proposal addresses current shortcomings in STEMM related fields. For example, the reported
proportion of faculty in basic science departments at medical schools that are from underrepresented
minorities ranges from only 6.3% to 8.9%2. The low percentage of faculty meeting diversity, equity and
inclusion (DEI) criteria underscores the need for programs like the VA SRP to increase the diversity of
scientists at entry level positions, which will increase the number of talented DEI eligible students who
develop a passion for science and continue a research career at the VA. This SRP counteracts the limited
diversity in science and medicine by providing competitive financial compensation and sustained
mentoring of students who qualify under the DEI criteria, relatively early in their educational trajectory
while there is still an opportunity to make an impact. We plan to identify and recruit 6-8 motivated
undergraduate or medical students each year, who have an interest in biomedical research. Program
participants will be able to choose from a broad range of research topics, exploiting the diverse and
exciting research areas represented at VABHS, each of which is fully aligned with the VA mission. Each
student will be paired with an experienced mentor, who will engage frequently with the student and ensure
an enriching and productive research adventure. These research and mentoring experiences will be
supplemented by educational, professional and social activities designed to instill confidence and build
community among participants.
A number of strengths and innovations have been incorporated in this proposal, including: 1) the
experience and infrastructure to support students and mentors has already been established during our
pilot SRP at VABHS; 2) a highly qualified team of principal investigator/program directors with a strong
commitment to mentoring, as well as extensive knowledge of VA mechanisms of onboarding and
compensation of students; 3) access to students from, and support of, three prestigious
colleges/universities (Stonehill College, Northeastern University, and Boston University School of
Medicine; 4) a remarkable pool of accomplished faculty mentors at VABHS with expressed interest in
training and mentoring students for this SRP; 5) a diverse selection of research topics and fields from
which SRP students can choose for their internship; 6) the fully immersive nature of the program, where
hands-on research experiences will be integrated with activities to promote educational development and
networking of participants; 7) an efficient plan for the socio-economic and educational support of DEI
participants; 8) a robust evaluation plan using input from SRP mentors and student participants to refine
and improve the program. This carefully structured program plan, with support systems and tracking
mechanisms in place, lays the foundation for DEI students to thrive in their future scientific endeavors.

Public health relevance
ASPIRE (Advancing Scientific Potential through Inclusive Research Experiences) is a summer research program (SRP) at the VA Boston Healthcare System (VABHS) that will provide students from underrepresented backgrounds with active participation in hands-on basic and translational research projects under the guidance of highly accomplished VABHS faculty who are experienced mentors. Our immersive mentored research program is coupled with educational and career development activities aimed at building community among ASPIRE scholars, mentors and VABHS colleagues. ASPIRE will draw from outstanding undergraduate science students and research-focused medical students. The objectives of ASPIRE are to provide transformative research opportunities for those from underrepresented or disadvantaged backgrounds and to instill in our scholars the academic confidence and enthusiasm to aspire to a career related to scientific research or medicine.